BRain Aging and Cognition in Epilepsy (BRACE): A longitudinal investigation of vascular, genetic, and biomarker risk profiles in elderly patients with epilepsy

Epilepsy is the fourth most common neurological disease, costing the healthcare system approximately $15.5
billion annually and negatively impacting quality of life. The incidence and prevalence of epilepsy peaks over the
age of 55—a group that is particularly vulnerable to accelerated cognitive and brain aging, placing them at
increased risk for progressive neurodegenerative disorders, including Alzheimer's disease (AD). Given that the
most rapidly growing segment of the U.S. population is adults over the age of 55, the number of older
adults living with epilepsy will dramatically increase over the next several decades, presenting a major
public health concern. Therefore, there is a critical need to characterize cognitive and brain aging in older
adults with epilepsy, identify underlying mechanisms of accelerated aging, and target modifiable risk factors that
would prevent or mitigate cognitive decline and progression to dementia. We propose the first longitudinal,
multi-site investigation of cognitive and brain aging in older adults (55-90 years) with epilepsy in efforts
to identify vascular, genetic, biomarker and demographic risk factors for accelerated aging. We will
accomplish this goal by obtaining state-of-the-art neuroimaging, comprehensive neuropsychological, vascular
risk, and genetic/biomarker data on 100 patients with temporal lobe epilepsy (TLE) and frontal lobe epilepsy
(FLE) from three geographically and racially/ethnically diverse epilepsy centers. We will follow these patients
longitudinally, examine their imaging and cognitive trajectories over 5 years, and compare their trajectories to
100 patients with mild cognitive impairment (MCI) and 100 normal aging controls. We will then examine the
influence of vascular, genetic (apolipoprotein 4), and cerebrospinal fluid biomarker (i.e, amyloidβ and tau) risk
profiles on cognitive decline and identify baseline factors that increase risk for progression to dementia. Our
scientific premise is that older adults with focal epilepsy will show age-accelerated cognitive and brain
aging comparable to that seen in MCI. We propose that elevated vascular risk and the presence of AD-
associated pathology will underlie the association between accelerated brain aging (i.e, regional
atrophy, white matter injury, and hypoperfusion) and cognitive decline in vulnerable patients.
These goals are aligned with the 2014 NINDS Benchmarks for Epilepsy Research, which prioritize limiting or
preventing adverse consequences of seizures and their treatment across the lifespan. They are also aligned with
the AD/Alzheimer's Dementia Related Dementias (ADRD) research goals of identifying risk factors (i.e.,
seizures) for progression to dementia. The current project has strong implications for public health because it
aims to identify individual predictors of cognitive decline that could help to prevent disabilty and progression to
dementia, which would have an immediate and sustained impact on patient care. Furthermore, this grant will
explore the bi-directional link between AD and epilepsy, would could lead to therapeutic opportunities for both
diseases and other disorders of aging.

Public health relevance
NARRATIVE This goals of this project are to (1) investigate longitudinal trajectories of cognitive and brain aging in older adults with epilepsy, and (2) identify modifiable risk factors to mitigate or prevent cognitive decline and progression to dementia. This research will be accomplished by combining advanced structural, diffusion, and perfusion imaging with neuropsychological, CSF biomarker and vascular risk factor data to model cognitive and brain changes, as well as moderators of change, over a 5-year period. The information gained from this investigation may help to shift epilepsy care beyond seizure control to include factors to protect and promote brain health in our elderly patients.